Dissecting the Mechanism of Polycomb Eviction by the BAF Complex

PROJECT SUMMARY
Thousands of cancer samples sequenced over the past decade have revealed that the chromatin remodeler
complex, mSWI/SNF (BAF), is mutated in 20% of all cancers. How these mutations in BAF contribute to
tumorigenesis is poorly understood, in part because the roles and functions of individual BAF subunits are not
well characterized. Studies are further complicated by the combinatorial diversity of the BAF complex both
within and across cell types. Together, these factors have made it difficult to define the mechanistic
contribution of BAF mutations to the cancer, despite the abundance of cancer genome data. My research in
the Crabtree lab will utilize a rapid, reversible assay that combines chemical-induced proximity and chromatin
immunoprecipitation (ChIP) to inducibly recruit BAF to a specific genomic locus in living cells and measure
immediate downstream effects. Developing this assay has been a major step forward in studying the BAF
complex in vivo, as observations from previous studies in vitro have not always held up in living cells. Using
this assay, our lab discovered that one mechanism by which BAF remodels chromatin is by evicting Polycomb
repressive complexes (PRCs) from chromatin. Indeed, mutated BAF complexes that are catalytically inactive
or found in malignant rhabdoid tumors (MRTs) are unable to evict PRCs from chromatin. Importantly, MRT
patients have responded positively to PRC inhibitors in clinical trials. Thus, at least in the case of MRTs,
disrupting BAF's PRC eviction function contributes to a cancer state that is treatable by PRC inhibitors. MRT is
a rare cancer in which 100% of disease cases contain a null mutation in a single BAF subunit. For the vast
majority of the 20% of all cancers involving BAF mutations, mutations are rather nonspecific to a particular
cancer type. In this research plan I will utilize our lab's in vivo assay for studying chromatin remodelers,
biochemical and genomics methods, and cancer mutation data to (1) define all BAF subunits required for PRC
opposition, especially via PRC eviction; and (2) define the range of BAF subunit mutations found in cancers
which produce a mutant BAF complex that cannot evict PRC from chromatin. This is an important question to
answer because patients carrying such mutations that impair BAF-mediated PRC eviction would potentially
respond positively to PRC inhibitors. Thus, results from this study will immediately identify potential novel
cancer subsets treatable with PRC inhibitors. More broadly, understanding the critical opposition between BAF
and Polycomb will identify new targets for therapeutic development.

Public health relevance
PROJECT NARRATIVE These studies will utilize novel chemical tools and cancer mutation data to advance the definitive understanding of a key mechanism by which the most highly mutated chromatin remodeler in cancer, BAF, produces chromatin accessibility. Defects in this key mechanism have been observed in cells which express mutated BAF complexes found in cancer and which are responsive to cancer therapies currently in clinical trial. This proposal aims to identify the full range of BAF mutations that result in mutated BAF complexes unable to execute this key mechanism, with the ultimate goal of expanding the treatable fraction of cancers containing mutations in BAF.